Training Program for Cancer Prevention and Control

PROJECT SUMMARY
The Ohio State University Comprehensive Cancer Center (OSUCCC) seeks its first renewal of its “Cancer
Prevention and Control Training Program” (CPCTP) for postdoctoral fellows. The philosophy of this program is
to foster transdisciplinary team science training through high quality mentorship to reduce the cancer burden in
high-priority areas in our communities and beyond. This is done by providing state-of-the-art research training
across the cancer control spectrum from the laboratory to the clinic and community, high quality research
infrastructure, and relevant didactic course work. The co-Program Directors (co-PDs) are Drs. Peter Shields
(Deputy Director, OSUCCC) and Chyke Doubeni (newly recruited to OSUCCC as Associate Director for
Diversity, Equity and Inclusion). Dr. Ce Shang is the Associate Program Director (APD). The transdisciplinary
training includes an emphasis on dual mentorship, transdisciplinary mentorship and biostatistical/bioinformatics
advisors. During the current grant cycle, there were several enhancements of the program including: 1)
formalizing the mentoring team structure; 2) enabling early stage investigators to serve as primary mentors
with senior mentor support; 3) securing an additional $3000 salary stipend through institutional funding; 4)
expansion to Nationwide Children’s Hospital for a lifespan approach including research on adolescents and
young adults; and, 5) securing an additional fellow slot with institutional funding. Despite the challenges of the
COVID-19 pandemic, all goals were met for training. To date, there have been 9 fellows enrolled in the
program, 2 who have completed their training and are now in academic tenure track positions, and 2
completing their training with offers for academic appointments. Among the fellows, 78% were women, and
33% were from disadvantaged communities or were an under-represented minority. Five of 9 were recruited
from other institutions. In the next cycle, we will: 1) increase the number of slots from 3 per year to 4 per year
(plus the one slot funded through institution support, total 5); 2) develop a new course for Cancer Prevention
and Control; 3) begin a yearly scientific symposium for current and former fellows; 4) provide funding to fellows
for the use of shared resources; and, 5) enhance efforts to recruit and retain under-represented minority
fellows under the leadership of Dr. Doubeni. The CPCTP has internal and external advisory committees. There
are 39 mentors (including 13 early career mentors [ECM]), all of whom have track records for peer-review
funding (ECM have career development awards). Particular strengths among the faculty include expertise in
carcinogenesis, cancer risk, behavioral interventions, survivorship, nutrition, health equity, community-engaged
research and tobacco control. While the OSU has several other training programs, there are essentially none
that overlap with the CPCTP. The training program would be administratively managed through the OSUCCC
Center for Cancer Mentoring, Education, Leadership, and Oncology-related Training (CAMELOT), a
comprehensive resource established in 2018. Plans are in place for ongoing trainee, mentor and the overall
program evaluations.

Public health relevance
PROJECT NARRATIVE Cancer prevention and control research remains a high priority for the NCI. The proposed training program will train cancer control and prevention researchers to become independent and productive scientists to advance the national priorities in improving access and quality of cancer prevention, detection and treatment and to advance the national goal of further reducing the burden of cancer.